Development of Injectable Super-Lubricious Microgels for Sustained Release of Platelet-Rich Plasma to Treat Post-Traumatic Osteoarthritis

Project summary
Post-traumatic osteoarthritis (PTOA) is a painful, debilitating and expensive joint disease that conservatively
impacts 5.6 million people at any time in the United States. Currently available clinical treatments are mostly
palliative and fail to suppress cartilage degeneration or synovial inflammation or to promote tissue regeneration.
Consequently, osteoarthritis progresses to an end-stage disease where total joint replacement is the only
answer. Our aim is to provide an injectable solution for the treatment of PTOA, through the fabrication of super-
lubricious microspheres loaded with platelet-rich plasma (PRP), which is blood plasma that has been spun down
to concentrate the platelet component. These platelets contain more than 300 bioactive molecules that play
critical roles in controlling and resolving inflammation, while also stimulating cells within the joint to proliferate
and regenerate tissues such as articular cartilage. Unfortunately, direct injection of PRP into the knee joint has
shown inconsistent efficacy in the clinic, mainly because the harsh environment within the osteoarthritic knee
rapidly breaks down and destroys the bioactive molecules rendering them useless for therapeutic effect.
Therefore, we propose to fabricate lubricious injectable polyethylene glycol (PEG) microspheres for injection into
the intra-articular knee space that cannot be cleared by the body with the synovial fluid turnover. We will evaluate
the incorporation and release as well as bioactivity and immunotoxicity of PRP from the hydrogel system, through
both quantification of specific proteins released over time and in vitro cellular response studies, respectively.
Finally, PRP-loaded microspheres will be used in a mouse model of knee injury and osteoarthritis to determine
the ability for our system to i) modify the intracapsular inflammatory state, ii) stop cartilage degeneration, iii)
promote new cartilage formation and, iii) restore joint homeostasis.

Public health relevance
Project narrative Post-traumatic osteoarthritis (PTOA), which affects more than 3 million Americans and totals billions of dollars in socioeconomic costs, is typically initiated following an injury to the knee, followed by joint instability, which then progresses to a state of excruciating pain and limited mobility. Despite the huge impact of osteoarthritis on American society, there have not been significant breakthroughs in the treatment of this disease. Our aim is to provide an injectable solution for the treatment of PTOA, through the fabrication of super-lubricious microspheres loaded with a concentration of bioactive molecules, namely platelet-rich plasma, capable of modifying the local inflammatory response, stopping the degeneration and initiating regeneration of articular cartilage, ultimately restoring joint homeostasis and health.